Developmental Funds

Since this submission is a competitive renewal, we will first present a brief Background to describe how our Developmental Funds have been/will be used. We support four Developmental Fund Projects annually, at $45-50K per project. Projects are for up to two years; second year funding competes in the pool with first year funding applicafions. Our initial goal for our Developmental Funds was to facilitate introduction of molecular imaging to UCLA cancer research; to bring the strongest molecular, cellular and cancer researchers into the imaging arena and to proselytize for use of non-invasive imaging in fundamental cancer research. In our current funding cycle, three of the four Research component Projects were new, and grew out of Developmental Funds Projects. Funding our competing ICMIC renewal is perhaps the best objective testimony that we achieved our goal. The narratives below describe proposed Developmental Fund Projects for year 1 of the renewal application. During this current cycle, the Jonsson Comprehensive Cancer Center and the Dean for Research for the David Geffen School of Medicine have also contributed funds to support related projects, in consultafion with Dr. Herschman (for details see Secfion A, Description).